High-Throughput In Vitro Analyses of Trauma-Induced Tauopathy

PROJECT SUMMARY
Chronic traumatic encephalopathy (CTE) is a neurodegenerative disease associated with
repeated mild traumatic brain injury (TBI). CTE is among the many neurodegenerative diseases
characterized as tauopathies, wherein the protein tau, which is usually associated with
microtubules in the axons of neurons, becomes separated from microtubules, initiating a
degenerative cascade and leading to eventual neurofunctional loss. There are currently no
pharmacological treatments available for CTE patients, so any treatment that could limit or
reverse tau-associated dysfunction would have an important impact on TBI patient outcomes.
Moreover, given the similarity between CTE and other tauopathies, insights into CTE treatment
could be broadly applicable to other common neurodegenerative diseases.
We have recently developed an in vitro model that directly links mechanical injury to tau pathology
in cultured neurons. One notable outcome from our prior studies is that we found that synaptic
dysfunction (measured using patch clamp) is correlated with mislocalization of tau to dendritic
spines (measured using fluorescent imaging). This result suggests that this relatively simple
image-based readout could be used for screening the effects of pharmacological agents on the
functional progression of trauma-induced tauopathy.
There are currently no high-throughput in vitro models for screening the effects of
pharmaceuticals on trauma-induced tauopathy. We have developed several cell stretching
systems, both for neurotrauma and other applications. However, all of these systems are far too
low-throughput for performing drug discovery studies. Thus, our goal is to scale up our current in
vitro neurotrauma model to a high-enough throughput for drug screening studies. We will design
a new stretchable multi-well plate for neuronal cell culture and a new high strain rate stretcher
that can apply trauma-like loads to the cells in the plate. In addition, we will employ machine
learning based algorithms to quickly and efficiently analyze the data collected from our new
device. Finally, we will use the device to test inhibitors known to be effective against other aspects
of neuronal injury affect tau mislocalization

Public health relevance
PROJECT NARRATIVE Chronic traumatic encephalopathy (CTE) is a neurodegenerative disease, likely caused by head injury, for which there are no pharmacological treatments and no simple methods for testing the efficacy of potential drugs. We recently developed an experiment that can mimic early-stage CTE in the lab and aim to use it to screen for potential treatments. To do so, we need to scale up our method; so, the goal of this work is to design and build the infrastructure to do the large number of tests necessary for drug discovery studies.